Trauma-informed, resilience-based telehealth intervention for improving HIV prevention and HCV care for persons who inject drugs in the Deep South

PROJECT SUMMARY/ABSTRACT
Persons who inject drugs (PWID) are at elevated risk for HIV and Hepatitis C Virus (HCV) due to needle
sharing and unsafe sexual practices. Amidst the unprecedented opioid epidemic, injection drug use (IDU) has
increased in the rural areas of the Deep South. Recent outbreaks of HIV and the ongoing HCV epidemic
among PWID living in the rural USA underscore the importance of promoting HIV Pre-Exposure Prophylaxis
(PrEP) and HCV care, and medications for opioid use disorder (MOUD) for PWID. Traumatic experiences, like
Adverse Childhood Experiences (ACEs), may lead to IDU, unsafe sexual practices, lower HIV testing, lower
PrEP use, higher perceived stigma, and lower resilience in later life. Tailored behavioral intervention for PWID
is urgently needed, particularly given the health disparities experienced by PWID living in the rural Deep South.
One innovative approach is to reach PWID via telehealth interventions for promoting PrEP, HCV care, and
MOUD. Thus, the scientific objective of this K01 is to assess barriers and facilitators that PWID, living in the
rural areas of Georgia and South Carolina, face in obtaining PrEP, HCV care and MOUD, and then use these
findings to inform the development of a theory-driven, trauma-informed, and resilience-based telehealth
intervention designed to increase willingness to uptake care. The career development objective of this K01 is
to obtain the comprehensive mentored training necessary to develop expertise in improving HIV prevention,
HCV care and MOUD for PWID in the Deep South through telehealth interventions. It is supported by the
highly productive research environment at the University of Georgia and a team of accomplished researchers
in HIV and HCV prevention and care, MOUD, trauma-informed care, resilience-based stigma reduction, and
telehealth intervention development and implementation. This mentored training experience will provide
expertise in behavioral intervention development; adaptation of existing evidence-based interventions;
telehealth intervention development and implementation; theater testing methods; randomized trial designs;
analytic techniques for assessing intervention feasibility, fidelity, acceptability, usability, and efficacy. Training
outcomes are linked to three specific aims. In Aim 1, I will assess the perceptions of PWID and healthcare
providers and policymakers to identify barriers to and facilitators of PrEP, HCV care and MOUD uptake in the
context of intersecting stigma. Using these findings in Aim 2, I will develop a theory-driven, multi-component
telehealth intervention to improve HIV prevention, HCV care and MOUD uptake among PWID with 6 bi-weekly
sessions. In Aim 3, I will evaluate the feasibility, acceptability, and usability of the telehealth intervention with a
randomized pilot trial with 50 PWID living in the rural Deep South. This project is responsive to the NIDA
priorities of trauma research, prevention services, and social determinants of health to optimize HIV prevention
and HCV care continua among PWID in the Deep South.

Public health relevance
PROJECT NARRATIVE Amidst the ongoing opioid epidemic, injection drug use has increased in the rural areas of the Deep South, and persons who inject drugs (PWID) are at higher risk of contracting HIV and Hepatitis C Virus (HCV). Given the lack of access to HIV pre-exposure prophylaxis (PrEP) and HCV care and medications for opioid use disorder (MOUD), PWID living in the rural areas of the Deep South are at elevated risk of contracting HIV and HCV, yet few tailored, innovative, trauma-informed approaches are available for this at-risk population. The proposed plan for career development and research focuses on this critical gap by assessing barriers to and facilitators of PrEP, HCV care and MOUD for PWID in the rural areas of the Deep South and then using these findings to develop and pilot-test a tailored, multi-component, trauma-informed, and resilience-based telehealth intervention that aims to increase awareness of and willingness to use PrEP and HCV care and MOUD in this population.